Core A-Administrative

PROJECT SUMMARY/ABSTRACT – CORE A
The Administrative Core (A) is responsible for supporting the research scientific agenda, fiscal oversight, and
facilitating communication across the Providence/Boston CFAR. The Core assures the overall success of the
CFAR by managing resources to investigators to assure maximal impact on HIV/AIDS research and the
communities we serve. The Core is led by Dr. Susan Cu-Uvin, Professor of Ob-Gyn and of Medicine with
Associate Directors, Dr. Jerrold Ellner of BUMC, Professor of Medicine and Chief of Infectious Diseases and Dr.
Thomas B. Kepler, BUMC, Professor and Vice Chair, Department of Microbiology. The CFAR brings together
two major academic institutions, Brown University and Boston University, a system of hospitals in Rhode Island
(Lifespan), and a major urban hospital in Boston (Boston Medical Center). The Core is central to fostering HIV
related research, scientific communication, mentoring, training, education, and community outreach by providing
the infrastructure and operational services to stimulate multidisciplinary research and integration of activities
across campuses. Core A will promote basic, clinical, behavioral and translational research at participating sites
through the following aims: 1) provide the leadership and administrative infrastructure for the successful
operation of the CFAR and its collaborating institutions; 2) promote research that addresses the needs of the
CFAR investigators and the impacted communities in Providence, Boston, our constituencies and our
International sites; 3) promote the development of HIV researchers at our institutions through adequately
resourcing the Developmental Core and assuring optimal usage of resources.